Enhancing Assisted Reproductive Technologies with Deep Learning and Data Visualization

PROJECT SUMMARY
Assisted Reproduction Technology (ART) is a clinical treatment for infertile couples who want to achieve a
pregnancy. In ART, embryologists fertilize eggs retrieved from the patient or a donor, culture the resulting embryos
in vitro, and then transfer the selected embryo(s) to the mother's uterus. While ART is responsible for 1.9% of babies
born in the United States as of 2018, selecting which embryo to transfer is a signiﬁcant challenge. The difﬁculty
comes from the complexity of confounding factors and the lack of understanding of human pre-implantation
embryo development. Because of this difﬁculty, multiple embryos are often transferred to increases the potential of
success, resulting in multiple pregnancy rates of nearly 20%, which can lead to signiﬁcant morbidity and medical
expenses to patients. The ideal is to transfer only a single embryo, but this necessitates the ability to select the
best embryo from a cohort. Here, we propose to create a clinical decision support system to improve embryo
selection in ART.
To this end, we will develop novel deep learning models for robust embryo feature extraction and interactive
data visualization methods for human-in-the-loop analysis. We will ﬁrst extract and analyze visual features from
routinely collected images of embryos. We will then combine these visual features with patients' electronic health
record (EHR) data to develop interpretable computation models that score embryos on their viability. We plan to
integrate our machine learning solutions into an easily accessible cloud service platform that will be adaptable
across clinics to improve ART embryo selection and clinical data analysis.
Our research goals will be achieved by novel machine learning-based models for morphological feature extrac-
tion and importance estimation of each confounding factor and a clinical decision support system for ART. For
morphological feature extraction, we plan to conduct semi-supervised learning of convolutional neural networks
to minimize manual labeling that requires extensive human effort. Our feature extraction model will be the ﬁrst
comprehensive classiﬁcation and segmentation method for ART. To aid in embryo selection, we will develop
novel deep learning-based models to predict probabilities of achieving pregnancy by accepting visual features and
EHR data as the input. We will also develop visual analytic tools that allow analysts to better understand and steer
these deep learning models. We will estimate the importance of each input interpretable factor in embryo selection
to explain the prediction to embryologists. Finally, we will develop EmbryoProﬁler, a clinical decision support
system for ART, that combines our machine learning-based models with a user-facing suite of visual analytic
tools to support user guidance and clinical decision making. EmbryoProﬁler will help facilitate daily operation in
clinics, foster human-guided decision making, enrich data-driven embryo analysis, and enhance the ability to
select the developmentally most competent embryo for transfer to improve ART success rates. Our project will
create state-of-the-art analysis approaches for ART clinicians.

Public health relevance
PROJECT NARRATIVE Assisted Reproductive Technology (ART) is a widespread treatment for infertility, over 300,000 treatment cycles were performed in the US in 2018, but success rates remain low. In this project, we will develop novel machine learning algorithms and a clinical decision support system to assist embryologists in embryo selection. Our tools will also enable embryologists and biologists to obtain new information on the earliest stages of human embryo development, which will advance the fundamental science of human biology and lead to further improvements in ART practice.